2022 Bioanalytical Sensors Gordon Research Conference and Seminar

PROJECT SUMMARY/ABSTRACT
Healthcare has entered an unprecedented time when rapid sensing of large amounts of data and processing of
that data yields information about human health and disease that was unattainable just several years ago. This
was accelerated by the pandemic, where measurement sciences was at the frontline of the COVID-19
response with rapid genetic, antigen or antibody tests. This demand for measurement science and bioanalysis
will continue, requiring an educated workforce of practitioners and researchers who can use this information to
solve the world's challenges in human health and disease crucial to positive outcomes in healthcare. As such,
with rapid advances in biology, genetic and protein analyses, and computational design and assessment,
together with low-cost manufacturing processes, electronic devices, and novel materials and nanotechnology,
there exists an unmet demand for a forum for in-depth discussions and interactions between investigators at
the forefront of these fields, working to solve the world's challenges in health-centered sensing. The 2022
Bioanalytical Sensors GRC seeks to fulfill this need in an intimate and scholarly setting. The broad, long-term
goal of this application is a sustainable Bioanalytical Sensors Gordon Research Conference (BAS-
GRC)/Gordon Research Seminar (GRS) culture that is forward-thinking in its approach to solving difficult
biomedical measurement and analysis challenges. In this highly interdisciplinary conference, the week will
progress through cutting-edge topics that span from the smallest nanoscale elements in molecular recognition
and intracellular sensing, to human scale wearable/implantable devices, to large scale environmental
monitoring in agriculture and our environment. The audience for this conference is from many research
backgrounds, including engineering, chemistry and physics, to life sciences and agriculture. Participants from
industry, entrepreneurs, clinicians, and practitioners are an integral part of translating cutting-edge technology
into the field. Students, young investigators, and established experts will come together with them to discuss
the latest challenges and opportunities in sensing and analytics at the interface between biology and devices.
This conference will have a direct impact on the Mission and Goals of the NIH, especially the NIBIB. The Aims
and Objectives of the 2022 BAS-GRC/GRS target the integration of investigators in the physical and
engineering sciences with the life science community to solve difficult problems with improving human health.
Research discussion will focus on: single molecule resolution measurements, wearable/implantable devices,
sensing in the brain, new technologies for rapid pathogen detection and identification, health diagnostics, and
monitoring of a healthy environment to foster better nutrition, access to clean water, and air. Finally, data-
intensive assessment tools dovetail into all these areas and thus has the potential to move forward basic
research and medical care. Additionally, a major focus is to provide a training environment for the next
generation of diverse, interdisciplinary biomedical investigators.

Public health relevance
PROJECT NARRATIVE The Gordon Research Conference on Bioanalytical Sensors (GRC-BAS) aims to promote the dissemination, discussion, and implementation of cutting-edge biological, biomedical, and biomolecular technologies for improving health diagnostics, environmental monitoring, and the betterment of human lives around the globe. The 2022 GRC-BAS focuses on sensing across length scales from single proteins, intracellular level, tissue level, and at human scale for the better detection, treatment, and prevention of human disease. Funding the GRC-BAS will bring experts and practitioners together in a forum for cross-pollination of subfields to push the boundaries of bioanalytical science towards better devices, techniques, and diagnostics in the future.